Examining HIV-related Stigma and HIV Testing Among Formerly Incarcerated African American Youth

Project Summary/Abstract
Persistent HIV health disparities impacts African Americans and are a public health priority. Despite declining
HIV rates nationally, African American communities continue to experience disproportionate HIV burden and
increasingly account for the largest share of HIV-related morbidity and mortality in the United States. These
concerning disparities necessitate research to inform robust responses that target priority subgroups within this
population. High rates of incarceration in many African American communities contribute to high HIV risk
environments, where the risks persist after release from the criminal justice system. Formerly incarcerated
African American youth (FIAAY, ages 18-24 years) in particular are at heightened risk in terms of sexual
behavior, illicit drug use, and challenged rates of HIV testing behavior after release. A prominent barrier to HIV
testing and timely diagnosis in this and other vulnerable populations is HIV-related stigma. Thus, more
research needs to not only examine stigma-related factors that reduce HIV testing behavior, but also create a
basis for interventions that can reduce stigma and increase HIV testing and HIV preventive behaviors in priority
populations, such as FIAAY. Towards these goals, my proposed study focusing on FIAAY in Louisville
Kentucky will allow me to: 1) develop a risk profile of HIV-negative or HIV status unknown FIAAY at greater
likelihood of having stigmatizing beliefs related to HIV infection and longitudinally examine the likelihood of HIV
testing based on this profile and 2) delineate mediating and moderating mechanisms by which stigma reduces
HIV testing in this population. These actions will help generate knowledge for the development of a multilevel
intervention targeting individual and structural factors to reduce HIV-related stigma and increase HIV testing
and prevention among this population of vulnerable youth. This Career Development Award will provide the
necessary knowledge and skills to conduct this and future research with criminal justice-involved populations.
This entails enhancing my skills in advanced statistical methods such as survival analysis and structural
equation modeling. In addition it will foster content expertise in decision science and the criminal justice
system, which will help inform intervention development. Study methods will include longitudinal survey data
collection (baseline, 12-months, 24-months) from 274 FIAAY in Louisville, KY. This research will inform the
development of stigma-related HIV-risk profiles for FIAAY who are less likely to test and delineate mediators
and moderators of the stigma-HIV testing relationship. If a relationship between stigma and testing is not
detected, other psychosocial factors will be examined to determine mediators and moderators of HIV testing.
This study has important downstream benefits for HIV prevention and treatment in this highly vulnerable
population.

Public health relevance
Project Narrative African American youth with a history of incarceration are at heightened HIV risk, thus early detection among this group is critical for linkage to prevention and care services, improving survival prospects, and reducing racial disparities in HIV. Despite the benefits of testing, HIV-related stigma remains a significant barrier to timely HIV diagnosis, however little research examines the mechanisms by which HIV-related stigma inhibits testing behavior. This study will delineate the relationships between stigma, stigma-related factors, and HIV testing and the information will be used to help generate knowledge for intervention development to improve HIV testing and stigma-reduction for formerly incarcerated African American youth.